All of Us Southern California Consortium (AoUSCC)

The overall goal of the All of Us Southern California Consortium, led by the University of California, Irvine, is to engage, recruit, and retain participants from the Southern California population with the goal to participate in the scientific mission of the All of Us Research Program, including participation in Partnered Research Studies (PRS) such as the Eyes on Health ocular imaging study.
We have assembled a multidisciplinary team with significant scientific strength, experience, and motivation to be one of the most effective and efficient All of Us consortia nationwide.
AoUSCC strives to promote access to health data and tools for participants, citizen scientists, and researchers to make queries and obtain impactful results using the All of Us research data in a privacy-preserving manner for the advancement of science in disease etiology and progression, health data research, data access, breakthroughs in artificial intelligence and machine learning, and precision medicine. We continue our work in promoting the data from the All of Us Research Hub to train future biomedical scientists.
The AoUSCC goals for Year 2 guided by national All of Us priorities include:
1) Maintain regulatory requirements and develop processes and timelines for completion.
2) Achieve All of Us adult enrollment goals in direct support of PRS enrollment and expectations, including those for the Eyes on Health.
3) Ensure facilitated participation of existing potential and existing AoU participants for enrollment and
retention.
4) Achieve electronic health record expectations, metrics, and provide twice-yearly electronic health records data transfers to the Data Research Center from UC Irvine.
5) Achieve performance metrics for sample quality related to biospecimens.
AoUSCC will work with the Program to advance the National Institutes of Health’s mission to deliver results that matter to the American public. AoUSCC will continue to work with the national All of Us leadership to focus on scientifically valid and measurable health outcomes.

Public health relevance
No PHR